Cancer Center Administration

PROJECT SUMMARY: CANCER CENTER ADMINSTRATION
The Administration Unit of the Fred & Pamela Buffett Cancer Center (BCC) is comprised of the following areas:
1) Business and Finance (budget and finance, human resources, public relations), 2) Administration and Faculty
Support, 3) Information Technology Services, and 4) Facility Management and Maintenance. BCC Administration
is led by Mr. Matthew Winfrey, Associate Director for Administration and External Affairs, and 17.5 FTEs report
to Mr. Winfrey either directly or indirectly. The Specific Aims of BCC Administration are as follows:
 Aim 1: Provide administration support to the BCC Director and the BCC Senior Leadership Team, including
the Associate Directors and Program Leaders, to promote BCC initiatives as outlined in the Strategic Plan.
 Aim 2: Oversee and coordinate the management functions of the BCC.
Since the last review, BCC Administration has continued to enhance and improve administrative services,
including but not limited to:
 BCC Administration oversaw the move of 43 Cancer Center Members into the Scott Research Tower over a
six-month period.
 Since 2015, 28 faculty members were recruited to the BCC, including several key leadership positions. BCC
administration assisted in these efforts and provided significant space and/or financial assistance for
recruitment of 24 BCC Members.
 BCC leadership (Director, Associate Director Clinical Research and Associate Director Administration) led
the efforts to centralize and integrate all cancer clinical research activities and personnel, including
contracting, regulatory, case management, and data management, into the BCC Clinical Trial Office (CTO).
 The BCC Administration implemented Forte/Advarra's data evaluation system – EVAL. EVAL replaces an
in-house system that had been used to deliver key requirements to meet CCSG guidelines (e.g., Data Tables
1 and 2).
 BCC Administration oversaw and coordinated an enhanced annual cancer research pilot project program.
 Since the last review, BCC Administration created the two following positions to assist with the research
and development efforts: 1) Major Grants Coordinator, and 2) Financial Grants Coordinator.